Human Clinical Phenotyping Core

The objective of the Human Clinical Phenotyping Core (HCP) is to promote excellence in human phenotyping, with a central mission to facilitate research on intellectual and developmental disabilities (IDD) by a diverse interdisciplinary team of investigators across the Einstein campus. The Core maintains a centralized easily searchable de-identified database of participants for access by Einstein investigators that includes information about data collection from the Neurogenomics and Translational Neuroimaging Cores, and provides continuity to HCP-enrolled participants as they traverse the different Cores and engage in research projects. The HCP is essential to the mission of the RFK-IDDRC to advance diagnosis, prevention, and treatment of children with developmental disabilities, and is positioned to serve as the central hub for a variety of RFK-IDDRC investigators for whom comprehensive phenotyping is key to understanding the implications of their work. It increases access to the populations of interest, increases the cost-effectiveness of research endeavors in well-characterized clinical populations, and facilitates collaboration among researchers with varied and complementary skill-sets and backgrounds.